TOTAL SYNTHESIS OF THE MDR REVERSING AGENT, HAPA

The synthesis of a novel MDR-reversing agent, hapalosin, is proposed. Along with this is also proposed the synthesis of several potential analogues of hapalosin.